Scaling up HPTN 074: a Cluster Randomized Implementation Trial of an Evidence-based Intervention for Antiretroviral Therapy for PWID in Vietnam

PROJECT SUMMARY
HIV-infected people who inject drugs (PWID) are less likely to engage in HIV care and use antiretroviral
therapy (ART) than other groups of HIV-infected people. In HIV Prevention Trials Network (HPTN) 074, an
integrated intervention combining systems navigation and psychosocial counseling (SNaP) was highly effective
in increasing ART uptake, viral suppression, and medication-assisted treatment (MAT) uptake among HIV-
infected PWID. Remarkably, SNaP also reduced mortality. Unfortunately, SNaP, like many evidence-based
interventions (EBI), may fail to achieve its full potential at the population level if barriers to implementation with
this vulnerable population are not addressed. In this study, we propose to compare two implementation
strategies for SNaP—both are based on the concept of Intervention Mapping. Intervention Mapping is a
formalized multistep process incorporating theory, evidence, and stakeholder perspectives to select a package
of implementation strategies that addresses barriers to EBI implementation. Tailored Intervention Mapping
expands upon Intervention Mapping by incorporating site-specific barrier assessment and locally tailored
implementation strategies. Our specific aims are: 1) To compare tailored Intervention Mapping (TIM) to
standard Implementation Mapping (IM) to scale-up SNaP in 42 HIV test sites throughout Vietnam; 2) To
measure the incremental costs of TIM compared to IM for SNaP implementation in Vietnam; and 3) To explore
the key characteristics of high and low performing HIV test sites for SNaP implementation in each study arm. In
Aim 1, we will conduct a two-arm, pragmatic, cluster randomized controlled implementation trial comparing IM,
a standard, one-size fits all multi-faceted implementation package identified through Intervention Mapping, and
TIM, a tailored implementation package using Intervention Mapping at both central and local levels. The
primary outcomes include fidelity of the SNaP intervention (implementation) and ART uptake (effectiveness).
Secondary implementation outcomes include penetration, acceptability, and cost; secondary effectiveness
outcomes include viral suppression and MAT uptake. The primary cost-effectiveness outcome (Aim 2) will be
the incremental cost-effectiveness ratio, expressed as the incremental cost per incremental ART uptake,
comparing TIM to IM. Upon completion of the trial, we will explore characteristics of high and low performing
HIV test sites (Aim 3) using both qualitative and quantitative data. This study will provide guidance for the
global implementation of the HPTN 074 intervention, SNaP, as well as other EBI. Importantly, this guidance will
not depend on the superiority of TIM relative to IM, but will be informative with a positive or a negative
comparison. With this information and guidance, the success of HPTN 074 will be replicable worldwide.

Public health relevance
PROJECT NARRATIVE People who inject drugs (PWID) have more morbidity and mortality from HIV infection than other groups with HIV infection. In a recent trial, an intervention that includes both assistance in engaging in HIV care (systems navigation) and brief psychosocial counseling improved use of HIV treatment, response to treatment, and use of medication-assisted treatment for substance use, while also reducing mortality. This trial, which will be conducted in Vietnam, examines two implementation strategies to identify the most effective approach to scale this intervention for global use.